A mixed-methods approach to understanding stress and hazardous drinking among same-sex female couples

PROJECT SUMMARY/ABSTRACT.
Sexual minority women (SMW; e.g., lesbian, bisexual) are 6-7 times as likely as heterosexual women to meet criteria for
alcohol use disorder, indicating a disproportionately high risk of hazardous drinking (HD) and associated negative health
outcomes. SMW's elevated HD risk is believed to be caused, in large part, by lifetime exposure to multiple and chronic
stressors. Although the association between stress and HD is well-established, little is known about how relationship
characteristics influence stress and HD among SMW. Intimate relationships confer many benefits and are protective
against stress-related negative health outcomes. Conversely, relationship stress may lead to unhealthy coping behaviors,
such as HD. The proposed study aims to understand the role of HD within same-sex female couples using both qualitative
and quantitative data at both the individual- and couple-levels. The specific aims for the K99 phase are to: 1) Explore
associations among couple-level relationship factors, stressors, and HD; and 2) Identify individual-level experiences
within same-sex female couples that influence drinking behaviors. The major goals of this Pathway to Independence
Award are the acceleration and completion of Dr. Cindy Veldhuis' training in alcohol-related research and the launching
of her career as an independent scientist with a tenure-track assistant professor position. Dr. Veldhuis is a psychologist
and a postdoctoral fellow funded by an NIH/NIAAA F32 National Service Research Award (F32AA025816) at Columbia
University. The two-year K99 phase will complete Dr. Veldhuis' training in sexual-orientation-related health disparities in
HD. With mentorship, Dr. Veldhuis will: 1) recruit and interview a sample of same-sex female couples (N=50 couples)
from the New York City area; 2) use a mixed-methods approach to examine HD and stress within couples to understand
predictors of HD in this at-risk population; 3) attend courses, seminars, and conferences related to alcohol use and misuse,
sexual minority health, mixed-methods and dyadic analyses, and professional development; 4) lead her own study on
SMW's health; 5) disseminate her findings; and 6) secure a tenure-track faculty position at a research-intensive university.
The proposed primary mentor Dr. John Pachankis, co-mentors Dr. LeBlanc and Dr. Hughes, and advisory panel members
Drs. Stone, George, Keyes, and Schrimshaw are experts in key components of the proposed K99/R00 and collectively
provide expertise ideally suited to facilitate the successful completion of the proposed training and research activities.
Columbia University is one of the world's most respected research centers and a world-class institution, and thus has the
resources needed for successful completion of the training (K99) phase of this proposed award. The three-year R00 phase
will allow Dr. Veldhuis to: 1) recruit a geographically and demographically diverse national sample of same-sex female
couples (N = 300 couples); 2) test a theoretical framework informed by the K99 findings using empirically validated
individual- and couple-level measures; 3) establish her program of research and laboratory; and 4) submit an R01 to
NIH/NIAAA. The proposed study extends findings from Dr. Veldhuis' F32 to understand how individual- and couple-
level characteristics of same-sex relationships influence HD and will provide preliminary data for her R01 application.

Public health relevance
PROJECT NARRATIVE Sexual minority women (SMW; e.g., lesbian, bisexual) are at disproportionately high risk of hazardous drinking (HD) and associated negative health outcomes compared to heterosexual women, likely due to their higher lifetime exposure to multiple and chronic stressors. Although there is a great deal of literature demonstrating that close, intimate relationships buffer stress among women in the general population, very little research has investigated HD within SMW's intimate relationships. This study aims to understand HD within same-sex female couples by considering both individual- and couple-level perspectives with the goal of informing the development of interventions to help couples implement healthy coping strategies.